Role of the stromal microenvironment in B-cell lymphoma progression and immune escape

PROJECT SUMMARY/ABSTRACT
This project focus in the biology of diffuse large B-cell lymphoma (DLBCL) that are common aggressive
malignancies with a curability rate of 65% despite intensive chemoimmunotherapy. DLBCL represents a
significant clinical problem for disparities research in that it is a potentially curable cancer, but one that is
universally fatal if untreated or improperly treated. Untreated DLBCL patients have an expected survival of <1
year, whereas with modern standard chemoimmunotherapy >58% of patients are alive and cured at 5 years.
The collective work of investigators involved in this administrative supplement demonstrated that despite the
high cure rates for DLBCL, outcomes remain heterogeneous. In fact, for DLBCL patients who are of African
ancestry outcomes are significantly worse: in the US, African American (AA) patients were diagnosed on average
10 years younger, more commonly presented with advance stage disease, and had worse overall survival than
their white counterparts. These disparities in lymphoid malignancies sparked interest in elucidating the role of
genetic ancestry in influencing differences among populations. As proposed in the parent R01, using
transcriptomic analysis of the lymphoma microenvironment for 4,655 DLBCLs, we defined four major lymphoma
microenvironment (LME) categories that associate with distinct biological aberrations and clinical behavior
independently to previously described genomic DLBCL subgroups. All these studies, genomic and
transcriptomics, have been focused primarily on populations of European descent, with no or minimal
representation of AA patients. However, there remains a gap in knowledge regarding the relationships between
the LME and clinical and demographic factors associated with worse survival including AA ancestry, rural status,
insurance status, and socio-economic status. In this supplement, we will close this gap by exploring these
relationships in an AA cohort study characterizing LME subtypes in relation to genomic alterations in cancer
cells. Thus, we propose the following Specific Aims: Specific Aim 1: Elucidate the characteristics of the LME in
AA DLBCL patients and the relationship with the epigenome; and Specific Aim 2: Characterize CAF and ECM
phenotypes in genetically defined LME DLBCL categories across multiethnic cohort. Our proposal will address
for the first time the role of the microenvironment in the biology and clinical outcomes in AA DLBCL patients. We
will determine the influence of race and ancestry in tumor biology and tumor immune responses associated with
African ancestry and their potential therapeutic and prognostic implications.

Public health relevance
Project Narrative The purpose of our studies is to understand the impact of African ancestry in the biology of a common type of aggressive lymphoma (diffuse large B-cell lymphoma). We will specifically determine how African ancestry affects the lymphoma immunity by analyzing non-cancer cells that constitute the lymphoma microenvironment. We expect these studies to help explain some potentially modifiable biological aspects related to worse outcomes in African American patients.